Core II: Cancer Registry Core

PROJECT SUMMARY/ABSTRACT
The Cancer Registry Shared Resource Core (CRSRC) will serve a key role in identifying and characterizing
cancer disparities in the multiethnic populations of Guam and Hawai‘i. The overall objective of the CRSR is to
provide key infrastructure support for cancer research and outreach activities of the Pacific Island Partnership
for Cancer Health Equity (PIPCHE). The CRSRC meets the requirements of PIPCHE shared resources to
enhance the ability to conduct cancer disparities research.
The CRSRC represents a partnership between the Guam Cancer Registry (GCR) and the Hawai‘i Tumor
Registry (HTR), the central cancer registries of the Territory of Guam and the State of Hawai‘i, respectively.
This partnership has been critical to the development of the GCR as a fully functioning registry through
technical support and training provided by the HTR and through the establishment of statutory authority for
cancer reporting and securing territorial funding. The CRSRC subsequently played a critical role in the
development of the Pacific Regional Central Cancer Registry covering the US Affiliated Pacific Islands.
The CRSRC serves as a critical resource for PIPCHE research and outreach. The CRSRC generates high-
quality cancer surveillance data through which cancer disparities can be identified and characterized. This
information is key to establishing PIPCHE research and outreach priorities. The CRSR also provides key
support for research and outreach activities.
The CRSRC will continue to serve as an important Core of the PIPCHE.
Specific Aim 1. Provide cancer data and related support for PIPCHE research projects (full and
pilot) and outreach activities.
Specific Aim 2. Build capacity for cancer surveillance and health disparities research at the
University of Guam (UOG) and the University of Hawai‘i Cancer Center (UHCC). This alignment will
allow for a synergy and sharing of data that would not be possible otherwise.